Nutritional Interventions to End Tuberculosis among persons with HIV in India (NUTRIENT-India)

PROJECT SUMMARY
India has the third-highest number of persons with HIV. One-quarter of deaths among persons with HIV
are due to TB. Undernutrition is the leading risk factor for TB in India. TB transmission from HIV-negative
persons likely fuels the TB epidemic among Indian persons with HIV. I hypothesize that population-scale
nutritional interventions would reduce TB incidence and mortality among persons with and without HIV. I also
hypothesize that, in an Indian context, in-kind nutritional supplementation would be more cost-effective than
cash transfers.
Models allow us to generate representations of real-world problems in mathematical language which can
be used to gain insights and to make projections. The proposed Nutritional Interventions to End Tuberculosis
among persons with HIV in India (NUTRIENT-India) study will have the following aims:
1. Quantify the long-term impact of population-scale nutritional interventions on TB incidence and mortality
among persons with and without HIV in the Indian state of Tamil Nadu using a microsimulation model
2. Estimate the impact and cost-effectiveness of a variety of nutritional interventions to decrease TB
incidence & mortality among persons with and without HIV
For aim 1, we will develop the microsimulation model and validate it. We will then calibrate the model using
data from national health surveys and primary data from the ongoing TB Learning the Impact of Nutrition
(LION) study of nutritional interventions. For aim 2, we will synthesize evidence on the impact of cash
transfers and in-kind transfers on nutritional status of recipients. Next, we will adapt an existing Markov model
to simulate three different nutritional interventions: 1) 2600 Kilocalories (Kcal)/d of food, 750 Kcal/d of food, and
Rs 500/month cash transfer. We will obtain cost estimates from the TB-LION study and NTEP programmatic
costs. After calibrating the model using data from TB-LION and the Regional Prospective Observational
Research on Tuberculosis (RePORT)- India consortium, we will conduct cost-effectiveness analysis of the
three different nutritional interventions.
The NUTRIENT-India study will help quantify the long-term impact of nutritional interventions on TB
incidence and mortality among persons with and without TB in India, The study will also define the most cost-
effective nutritional interventions in the Indian context. Thus, it will inform policymakers on why they must
address this critical TB risk factor that keeps TB entrenched in India and how they can intervene while making
maximal use of available resources.

Public health relevance
PROJECT NARRATIVE Undernutrition is a critical TB comorbidity and drives the TB epidemic in India. The NUTRIENT-India study will help quantify the long-term impact of nutritional interventions on TB incidence and mortality among persons with and without TB in India and define the most cost-effective nutritional interventions in the Indian context. Estimating cost-effectiveness of nutritional supplementation to mitigate the TB epidemic in India may incentivize Indian policymakers to wield nutritional policy effectively to attain their TB elimination goals.